Mechanisms by which M. tuberculosis 13KDa lectin modulates human immune responses

Mechanisms by which M. tuberculosis 13 kDa lectin modulates human immune responses Project Summary Study of novel proteins from Mycobacterium tuberculosis may be a critical step for improving diagnostic tools, therapies and immunoprophylaxis against tuberculosis (TB), one of the most prevalent infectious diseases wordwide. We have identified a 13 KDa ricin-like lectin from M. tuberculosis that was found to agglutinate red blood cells and induce cytokine expression by macrophages. Moreover, serum from active tuberculosis patients contained high levels of IgG against this lectin. In the present proposal, we aim to characterize the role of 13 KDa Mtb lectin on human immune responses. The specific aims of the study are to 1) characterize the innate immune response profile elicited by the 13 KDa Mtb lectin; 2) determine innate receptor(s) expressed on human APC involved in the recognition of 13 KDa Mtb lectin; 3) investigate the role of 13 KDa Mtb lectin in the infection/phagocytosis process of M. tuberculosis by human APC and 4) examine specific humoral and cellular immune responses against 13 KDa Mtb lectin in TB patients before and after antibiotic treatment. Our long-term goal is to determine whether 13 KDa Mtb ricin-like lectin plays a role in regulating human immune responses to TB focusing on it possible activity in controlling APC function. These studies could be important in revealing a new target for immunotherapy of tuberculosis.

Public health relevance
Project Narrative Development of this project may impact human health because understanding of interactions between Mycobacteria and human cells could be important in revealing novel targets for immunotherapy of tuberculosis as well as disease biomarkers. __SpecificAimsTextDelimiter__ RESEARCH PLAN SPECIFIC AIMS Pathways involved in pathogen recognition by antigen presenting cells (APC) orchestrate the immune system to eliminate infection. Receptors expressed on APC as well as pathogen-derived factors are thought to be critical to the outcome of optimal host immunity. Several innate receptors have been demonstrated to sense the most successful mycobacterial pathogen Mycobacterium tuberculosis (Mtb). In contrast, mycobacteria-secreted proteins may impact immune responses and influence protection in vivo. Our long-term goal is to elucidate the mechanims by which secreted proteins from M. tuberculosis regulate immune responses in humans. Our interest in this subject stems from the fact that we have previously shown that innate immune receptors (PRR) cooperate to sense a number of factors produced by M. tuberculosis influencing host resistance against this pathogen. Among possible mycobacteria- associated patterns, sugars are important codifiers which are recognized by host PRR. Thus, we have generated a non-redundant lectin database in an attempt to identify lectin (sugar binding proteins) domains from M. tuberculosis. Following bioinformatics analysis, we have identified a 13 kDa ricin-like lectin from M. tuberculosis (13 kDa Mtb lectin). Moreover, preliminary experiments demonstrated that recombinant 13 kDa Mtb lectin agglutinates red blood cells, induces cytokine expression by macrophages and is recognized by IgG present in the serum of patients with active tuberculosis (TB). These data prompted us to further study the mechanisms by which human APC sense the 13 kDa Mtb lectin. Characterization of novel proteins from M. tuberculosis is critical for improving diagnostic tools, therapies and immunoprophylaxis against tuberculosis, one of the most prevalent infectious diseases in Brazil. In the present proposal, we will perform a detailed characterization of the role of 13 kDa Mtb lectin on human immune responses. Specifically, this proposal aims to answer 4 questions: 1. What is the cytokine profile induced by 13 kDa Mtb lectin in human APC? 2. What are the receptors expressed on human APC involved in the recognition of 13 kDa Mtb lectin? 3. How does 13 kDa Mtb lectin influence uptake/phagocytosis of M. tuberculosis by human APC? 4. Does successful anti-tuberculosis treatment regulate humoral and/or cellular immune responses against 13 kDa Mtb lectin? Specific aims: 1- To characterize the innate immune response profile elicited by 13 kDa Mtb lectin. In prelimary work, using a macrophage cell line J774, we have found that recombinant 13 kDa Mtb lectin induces high levels of TNF production at the first 6h of stimulation. In addition, primary human monocytes from 3 healthy donors were tested and displayed similar results suggesting that human cells are responsive to this purified lectin. We will investigate the pattern of cytokine expression induced by the lectin in human antigen presenting cells (APC), namely macrophages and dendritic cells, two of the most important cells in the response against mycobacteria. To acomplish these goals, we will perform the following experiments: A- Cytokine gene expression. 13 kDa Mtb lectin triggers pro-inflammatory cytokines such as TNF at the protein level. Using an in vitro APC culture as a model, we will measure cytokine gene expression by real time PCR to first identify inflammatory pathways triggered by this mycobacterial protein. The time course of 1h, 3h, 6h and 12h will be chosen as we will define the innate response stimulated by the lectin. B- Cytokine profile. We will perform ELISA to measure levels of the cytokines IL- 12 (p40 and p35), IL-23, IL-17, TNF, IL-6 and IL-10 to define the pattern of cytokine induced by the lectin in human APC. We will also use CBA (cytokine bead array) flow cytometry to measure cytokines in overnight supernants of APC cultures. C- Receptor expression. Following pathogen recognition, DC regulates a number of receptors such as MHC class II, CD80, CD86, CD40 and CD1a. Expression of these receptors will be evaluated by flow cytometry to study whether the mycobacteria 13 kDa lectin regulates DC maturation/activation. 2- Determine the innate receptor(s) expressed on human APC involved in the recognition of 13 kDa Mtb lectin. Our prelimary data showed that 13 kDa Mtb lectin triggers the pro-inflammatory mediator TNF, suggesting the likely involvement of innate immune receptor(s) in this response. Two major families of receptors, namely Toll-like receptors (TLR) and C-type lectin receptors (CLR), have been demonstrated to participate in cytokine responses triggered by mycobacteria (1-9). Defining the receptors involved in 13 kDa Mtb lectin recognition could be an important step to understand immuno-pathogenesis of TB. We will test the specific hypothesis that these two families are involved in the host-13 kDa Mtb lectin interactions. We will determine the receptor(s) that sense this lectin by pursuing the following experiments: A- TLR involvement. Two approaches will be utilized: [A1 The cell line HEK-293-expressing TLR is a reliable tool for screening for pathogen-derived TLR agonists. Therefore, we will use this system to detect such response.] [A2 Neutralizing antibodies against TLR2 or TLR4 as well as pharmacological blocking reagents (TLR3, TLR7/8 and TLR9) will specifically be used to inhibit these pathwyas in primary human APC.] B- C-type lectin involvement. Human DC and macrophages express several CLR such as DC-SIGN, Dectin-1, MR and CR3 (5-8, 10) and (data not published). We will use blocking antibodies as well as specific blocking reagents (e.g. laminarin, glucan phosphate) to determine whether these receptors are involved in 13 kDa Mtb lectin recognition. C- Other receptors. An alternative hypothesis is that receptors other than TLR and CLR are involved in sensing this mycobacterial lectin. We will perform biochemical-based bait-prey experiments using recombinant 13 kDa lectin (as the prey) and membrane preparations from human DC or macrophages (as the bait) to study possible associated proteins. Additionally, a monoclonal antibody h¿s been recently generated and will be helpful to identifiy protein-protein interactions through co-immunoprecipitaion experiments. 3- Investigate the role of 13 kDa Mtb lectin in the infection/phagocytosis process of M. tuberculosis in human APC. Our preliminary data suggest that 13 kDa Mtb lectin interacts with surface receptors on murine macrophages. We will study whether this protein influences upatake/phagocytosis of Mtb by human APC by studying the following: A- Uptake. DC and macrophage uptake of green fluorescent protein (GFP)- or red fluorecence protein (RFP)- expressing mycobacteria will be measured by flow cytometry as well as confocal microscopy in the presence or absence of 13 kDa Mtb lectin. In paralell, M. tuberculosis will be treated with an anti-13 kDa Mtb lectin monoclonal antibody in attempt to inhibit host cell-pathogen interactions, and perhaps, uptake/phagocytsis process at 370C. B- Binding. Mycobacteria binding will be measured by co-culturing GFP- or RFP- expressing mycobacteria with DC and macrophages at 40C. At different time points (15 min, 30 min, 1h and 2h) after exposure, fow cytometry will be employed to quantify the degree of bacteria binded to APC and confocal microscopy will be used to observe pathogen-cell interactions. C- M. smegmatis-expressing 13 kDa Mtb lectin. From the bioinformatic analysis data, we found that the non-pathogenic mycobacteria, Mycobacterium smegmatis, does not present the gene Rv1419-encoded 13 kDa lectin (not shown). M. smegmatis that constitutively expresses this lectin will be generated and tested in human APC in vitro. Virulence parameters such as cytokine production and uptake/phagocytosis will be measured. 4- Examine specific humoral and cellular immune responses against 13 kDa Mtb lectin in TB patients before and after antibiotic treatment. Preliminary results suggest that TB patients with active pulmonary disease display increased levels of serum IgG against the 13 kDa Mtb lectin as well as enhanced IFN-gamma production by PBMC in ex vivo recall responses to the lectin. We will evaluate whether these 13 kDa Mtb lectin-elicited responses are altered in patients during the course of anti- mycobacterial chemotherapy. A- Humoral responses. We will perform ELISA to measure anti-13 kDa Mtb lectin IgG (total and subclasses) levels in the serum from active TB patients before, ongoing and after antibiotics treatment. B- Cellular responses. In vitro responses will be measured in PBMC cultures from TB patients and compared to that of healthy controls following exposure to recombinant 13 kDa Mtb lectin. Cells from TB patients before, ongoing and after antibiotic treatment will be utilized. IFN-gamma production from PBMC culture supernatants will de determined by ELISA. In addition, flow cytometry will be used to evaluate direct IFN-gamma and TNF production by T cells following exposure to 13 kDa Mtb lectin as well as T-cell proliferation as measured by CFSE dilution. A cohort of 40 patients monitored in the city of Juiz de Fora (Minas Gerais State) will be used to perform these studies. Accomplishing the specific aims outlined in this proposal will considerably expand the knowledge on how 13 kDa lectin from M. tuberculosis regulates human immune responses to this pathogen focusing on its possible activity in regulating APC function. The outcome of these studies will be important in revealing a new target for the immunotherapy of tuberculosis.